Non-destructive assessment of retinal differentiation capacity and developmental maturity

ABSTRACT
The ability to generate patient induced pluripotent stem cells (iPSCs) has revolutionized the field of
regenerative medicine. Like many researchers, we foresee a future where autologous stem cell-derived tissues
will be used to treat a wide variety of neurodegenerative disorders, including inherited retinal degenerative
blindness. One of the greatest hurdles for autologous cell replacement is that validated patient-specific
therapeutics are difficult to produce using traditional manufacturing strategies, which are designed for large
scale production of a single product to treat a large patient population. Despite this, decades of human
transplant experience (spanning many organs and tissue types) have consistently shown that immunologic
matching has a significant impact on graft function and longevity. To enable autologous cell production, we
recently reported development of a robotic cell culture platform with imaging capabilities, that can
automatically identify, pick, weed, and feed patient-derived cells over the life of a manufacturing campaign.
While a step in the right direction, several hurdles to efficient production of autologous cell therapeutics
remain. First, despite the use of well characterized iPSC generation protocols, significant variability between
patient iPSC lines with respect to retinal differentiation capacity exists. For iPSC lines that lack the ability to
efficiently differentiate into the target cell type, production costs and time are significantly increased. Second,
traditional methods used to evaluate the clinical suitability of a product are inherently destructive and require
repeat sampling throughout the manufacturing campaign (e.g., repeat immunohistochemical analysis during
differentiation to track development). Furthermore, it is impossible to evaluate the clinical product intended
for human use when destructive release tests are utilized (e.g., impossible to perform RNA-seq analysis on the
actual graft that will be placed in a human). In this application, we propose two specific aims which are
designed to address each of these major manufacturing hurdles. In Aim 1, we use imaging data collected during
iPSC generation and retinal derivation to train an AI algorithm to select lines with a propensity for retinal
differentiation. This would eliminate the wasted time and resources that are currently associated with using
lines that are difficult to differentiate into retinal tissue. In Aim 2, we will correlate developmental transcript
expression with unbiased imaging data collected throughout the retinal differentiation process, to identify
morphological cues that can be used to train our robotic platform to assess organoid maturity and enable non-
destructive clinical release testing. Upon completion of this program, we believe that we will have generated
image analysis algorithms that can be used with automated cell culture platforms to enable production of
patient iPSC lines with excellent retinal differentiation capacity, permit tracking of photoreceptor cell
development, and allow for the non-destructive qualification of the actual product intended for clinical use.

Public health relevance
NARRATIVE The death of photoreceptor cells in the outer neural retina is a leading cause of irreversible blindness in the United States. As the human retina is incapable of regenerating, cell replacement strategies are required to restore vision. In this application, we seek to develop an AI-guided approach to facilitate high-throughput automated manufacturing of clinical grade autologous photoreceptor cell therapeutics.